Clinician Scientist Training Program (CSTP)

Project Summary/Abstract
The Yale Division of Addictions, Department of Psychiatry at Yale School of Medicine requests a 6th 5-year
renewal for our Clinician Scientist Training Program, which has been providing intensive training in research
methods for clinical and translational investigation of drug abuse since 1991. Presently, the Clinician Scientist
Training Program supports three early career faculty members engaged in various aspects of drug abuse
research with a focus on treatment development. The support will permit the Clinician Scientists to spend 3-5
years at Yale’s Division of Substance Abuse obtaining clinical and research training under the mentorship of a
team of 53 senior investigators whose interests range from molecular neurobiology to health services research.
With about 100 externally funded research projects, the central theme of our research program is the
development and evaluation of innovative pharmacological and behavioral treatments for individuals with drug
addictions in a manner informed by emerging neuroscientific findings. Our multidisciplinary, translational
program enables us to conduct research that moves rapidly in both directions from preclinical projects
(“bench”) to clinical studies (“bedside”). The training goal for this program is to provide Clinician Scientist
Scholars at the junior faculty level with an opportunity to devote virtually full-time effort during the initial phase
of their careers to learning research skills and conducting research projects as a critical step toward launching
careers as independent research scientists. After initial work conducted with the support of this program, they
will be guided to develop scientifically meritorious research proposals (using, for example, R21 and R01
mechanisms) which will provide support for research that extends beyond the period of the program. Since the
onset of the program, we have provided training for 37 Clinician Scientists, many of whom are among the
leaders of their generation of drug abuse investigators.

Public health relevance
Project Narrative Addictions are arguably the most costly conditions to society. Thus, investigations into new and improved treatments for addictions are of vital importance. This proposal seeks support to train early career investigators at the junior faculty level for training as clinician scientists investigating drug addiction, with a focus on treatment development.